Translational Engineering in Cancer (TEC)

Project Summary/Abstract: Translational Engineering in Cancer
The Translational Engineering in Cancer (TEC) Program brings together 25 faculty, representing 12
departments at Dartmouth’s Geisel School of Medicine (Geisel), its Thayer School of Engineering and its
Guarini School of Graduate and Advanced Studies; and the Dartmouth-Hitchcock Medical Center (DH), with
research interests relevant to three central TEC Program themes: 1) Surgical image-guidance, 2) Radiation
monitoring and guidance, and 3) Cellular/molecular detection and contrast. The shared goals of the TEC
Program are to: 1) Utilize biophysical and bioengineering approaches to develop and translate new imaging,
engineering and treatment technologies that improve the care of cancer patients; 2) Impact cancer detection,
diagnosis, and treatment – nationally, regionally, and within the NCCC catchment area especially for
malignancies of the brain/CNS, breast, skin, head & neck, pancreas and prostate – by providing access to
novel imaging modalities, interventional protocols enhanced by imaging and image-guidance, and dosimetry
technology for assessing radiation treatments; and 3) Translate laboratory results into clinical studies via
development of novel technologies that fuel academic-industrial partnerships, as well as start-up ventures and
other industry relationships, to drive Dartmouth-generated technology towards clinical dissemination with the
goal of changing and improving practice. Peer-reviewed cancer-related research direct cost support currently
totals $6.4M, with NCI funding representing 53% ($3.4M) and total direct costs summing to $6.5M. Thirteen
(13) TEC Program Members currently have a total of 17 CCSG-defined R01-equivalent awards. Using the
same definition of cancer-related direct costs in 2014 (i.e., excluding all indirects as well as training and
administrative direct costs), peer-reviewed cancer-related research direct costs ($6.4M) are 44% less
compared to 2014 ($11.3M), but 60% of the 2014 total ($7.0M) was attributable to one large BARDA award.
Since 2015, the Program has 306 cancer-related publications, 51% (157) intra-programmatic, 25% (76) inter-
programmatic, 51% (156) with investigators from other institutions, and 11% (28) in high impact journals (i.e.,
impact factor >8), which are uncommon in engineering publications. Compared to 2014, intra-programmatic
remains high (51% and 60%), and inter-programmatic has increased, to 25% from 20%. During the proposed
funding period, TEC will leverage new Center for Imaging Medicine facilities in the Williamson building and the
significant expansion of Dartmouth’s Thayer School of Engineering Faculty and co-location with Computer
Science, as part of a major capital campaign recently announced to grow significantly its imaging and image-
guidance research base in surgical oncology.